Positive and negative impacts of prior knowledge on episodic memory consolidation

PROJECT SUMMARY
The study of how prior knowledge shapes new experiences is central to the science of memory and its role in
pathology, but there is a critical lack of understanding of how prior knowledge shapes the long-term storage and
transformation of a new memory. Current explanations of how episodic memories change over time put forward
the hypothesis that neural traces in the hippocampus become distributed across cortical regions (systems-level
consolidation), a process that unfolds over extended timescales through persisting neural dynamics that unfold
after learning. Emerging evidence conflicts with this, suggesting that prior knowledge can speed or even bypass
this process, such that increased cortical dynamics during and after learning results in the immediate generation
of a cortical memory representation that supports a stabilized memory (rapid consolidation). However, current
research focuses mainly on the impact of prior knowledge on memory accessibility, rather than characterizing
the quality of the enduring memory and its assimilation with other information, leaving open questions about how
prior knowledge governs the transformation of new memories and their integration into pre-existing cortical
networks. This application describes a 5-year plan to investigate how prior knowledge can enhance or distort
new memories, focusing on ways that prior knowledge shapes learning and consolidation of new events. The
plan consists of functional neuroimaging (fMRI) and non-invasive brain stimulation techniques (TMS), applied to
both well-validated and novel experimental approaches and targeting healthy human adults. The central
hypothesis is that, if prior knowledge is activated during new learning, memory for new items undergoes rapid
consolidation, regardless of if the encoded event is congruent with or conflicts with the activated knowledge.
Specifically, the activation prior knowledge during learning will increase cortical involvement during learning and
elevate cortical based neural dynamics in periods of awake rest after learning, relative to more hippocampal
based processing predicted by classic systems consolidation models. Critically, the rapidly consolidated
memories would be both more durable and more easily integrated with prior knowledge than if they were
unrelated to prior knowledge. Aim 1 will test these hypotheses with the prediction that new memories that are
congruent with prior knowledge will become more integrated with each other, using a novel test of behavioral
integration. Aim 2 will test parallel hypotheses when new experiences conflict with prior knowledge, using a well-
validated experimental design. Critically, the prediction is that the same rapid consolidation processes would
give rise faster and greater distortions in these memories. Completion of these aims will reveal novel insights
into how prior knowledge impacts the trajectory of new memories and will shed light on how dysfunction in this
process leads to pathology. This has the potential to aid clinical researchers in the development of treatments
for patients suffering from subtle impairments in memory, such as stroke patients.

Public health relevance
NARRATIVE The study of how prior knowledge shapes new experiences is central to the science of memory, but there is a critical lack of understanding of how prior knowledge shapes the long-term storage and transformation of memories for new events. We will examine how prior knowledge can exert both helpful and harmful influences on new memories, by investigating whether the activation of prior knowledge during learning triggers a ‘rapid’ consolidation process regardless of whether a new memory is congruent with or conflicts with prior knowledge. A more mechanistic description of when and how prior knowledge influences new memory formation may provide a better diagnostic tool for identifying the locus of memory impairment in patients with diffuse cortical damage, leading to improved treatments.